Determination of genome-wide splicing kinetics and their underlying regulation

Project Summary
The biogenesis of mRNA requires relatively small exons to be identified and stitched together from
within an expanse of intronic sequence. The majority of intron removal occurs co-transcriptionally on the
moving target of the nascent RNA complex. Adding to this complexity, introns are not always removed in
the same way. Rather, alternative splicing can give rise to proteins with distinct functions arising from the
same gene. Over the last few decades, a great deal has been uncovered about the mechanisms by which
complex molecular machineries regulate splicing. However, we still know very little about the kinetics of
splicing on its in vivo substrate, nascent elongating pre-mRNA. The co-transcriptional nature of most
splicing underlies why transcriptome-wide splicing kinetics have remained a barrier to progress in the field.
The rate of intron removal from nascent RNA is obfuscated by the transcriptional dynamics of the substrate
itself. In order, to determine co-transcriptional splicing rates, the kinetic parameters of transcription (e.g.
initiation rate, elongation rates and transcript cleavage rates) must also be determined. Here, we unveil a
novel technique called SKaTER-seq (Splicing Kinetics and Transcription Elongation Rates through
sequencing) and a sophisticated computational pipeline which together can simultaneously determine the
critical parameters of transcription and splicing rates transcriptome-wide. Our overall goal is to apply the
SKaTER-seq method in order to gain further mechanistic understanding of how splicing kinetics are
regulated. The first aim will determine transcriptional and splicing kinetics transcriptome-wide and
determine their relation to genomic, chromatin and trans-acting factors. The second aim will determine the
role of three chromatin components (H3K36me3, linker histone H1, histone variant macroH2A1) in the
establishment of transcriptional and splicing kinetics. This data will illuminate key unanswered questions in
the field about the role of chromatin, transcriptional elongation, and spliceosomal perturbation in directing
splicing outcomes.

Public health relevance
Project Narrative Our genes are made up of regions, called exons, that code for proteins interspersed with long non-coding elements called introns. Splicing, a critical step of gene expression, removes these introns and stitches together the exons into an mRNA which can be translated into a protein. This proposal seeks to use a novel assay called SKaTER-seq to determine the individual rates at which each intron is removed and will lead to a better understand of the underlying mechanisms that regulate alternative splicing and causes of splicing dysregulation in disease.